Pathways to Successful Aging Among Perinatally HIV-infected and Exposed Young Adults: Risk, Resilience, and the Role of Perinatal HIV Infection

For the past 18 years, CASAH has followed 340 predominantly Black and Latino/a youth with perinatally acquired
HIV (PHIV) and youth perinatally HIV exposed but infected (PHEU) – enrolled at ages 9-16 years from vulnerable
communities in New York City – documenting health risk and resilience across childhood, adolescence, and
emerging adulthood. Now in its fourth competing continuation (R01 MH69133-19), CASAH4, as it is known, is
following this cohort through young adulthood (YA; 20s-early 30s). CASAH has made significant contributions to
research on health risk and resilience and the social determinants of these outcomes in PHIV and PHEU youth
with over 125 publications and 80 scientific presentations, and has directly informed mental-health and HIV-
prevention interventions and service systems in the US and abroad. CASAH is guided by Social Action Theory
(SAT), and CASAH4 specifically examines: 1) the impact of HIV infection on behavioral health outcomes (e.g.,
mental health, sexual risk, substance use, adherence) and achievement of adult milestones (e.g., education,
vocation, independence); 2) how SAT-informed risk and protective factors affect YA behavioral health and
achievement of adult milestones; 3) trajectories of behavioral health across adolescence and young adulthood and
SAT-informed predictors of these trajectories; and 4) behavioral health outcomes and their SAT-informed
predictors among youth across global cohorts (e.g. US, Thailand, South Africa). CASAH4 has added biomedical
health indicators (inflammation and immune activation biomarkers associated with psychiatric and neurocognitive
function) to HIV RNA viral load and CD4+ cell count data already collected. With its ongoing and historical work,
CASAH has one of the most comprehensive longitudinal datasets on mental health, alcohol/substance use,
behavioral health, as well as milestone achievement among adolescents and young adults living with PHIV or
PHEU – a dataset ideal for machine learning (ML) and sharing with other multidisciplinary scientists. However,
gaps in the full CASAH dataset (e.g., unprocessed data, unscaled variables) and in data documentation act as
barriers to using it for ML and sharing it via NIH-supported data repositories. Thus, the aims of this one-year ML
data readiness administrative supplement are to prepare (collate, clean, document, test and share) the full CASAH
dataset (which will ultimately span 20 years and 10 waves of data collection) for use in ML applications and sharing
with a range of multidisciplinary scientists in accordance with the NIH goals to advance our knowledge of health
outcomes and social determinants of health in vulnerable young people affected by HIV. In this proposal, we add
expertise in ML data analytic approaches, data security and data transportability. Ensuring the transportability of
CASAH data will allow for cross-cohort studies with non-HIV populations (e.g., The National Longitudinal Study of
Adolescent to Adult Health; Boriqua Youth Study; ABCT) which will strengthen our ability to identify multimodal
determinants of health across critical developmental stages – much needed knowledge to develop evidence-based
interventions for youth with HIV, chronic health conditions, and affected by a range of health disparities.

Public health relevance
The aims of this one-year ML data readiness administrative supplement are to prepare (collate, clean, document, test and share) the full CASAH dataset (which will ultimately span 20 years and 10 waves of data collection) for use in ML applications and sharing with a range of multidisciplinary scientists in accordance with the NIH goals to advance our knowledge of health outcomes and social determinants of health in vulnerable young people affected by HIV. In this proposal, we add expertise in ML data analytic approaches, data security and data transportability. Ensuring the transportability of CASAH data will allow for cross-cohort studies with non-HIV populations (e.g., The National Longitudinal Study of Adolescent to Adult Health; Boriqua Youth Study; ABCT) which will strengthen our ability to identify multimodal determinants of health across critical developmental stages – much needed knowledge to develop evidence-based interventions for youth with HIV, chronic health conditions, and affected by a range of health disparities.